CONFERENCE ON HEMOCHROMATOSIS AND IRON DISORDERS

This request is for funds to help defray costs for the Fifth Conference of the International Association for the Study of Disorders of Iron Metabolism to be held at the Boston Marriot Copley Place in Boston, April II -13, 1995. This International Conference is held every two years. Previous meetings have been held in New York (1987), Brisbane, Australia (1989), Dusseldorf, Germany (1991) and Jerusalem, Israel (1993). The objective of the meeting is to bring together clinicians and scientists interested in sharing information to better understand and treat disorders of iron metabolism in humans. Funds are requested to pay for some organizational and operational costs and for travel and accommodation expenses of invited speakers.